Community Engagement Core

COMMUNITY ENAGEMENT CORE (CEC): ABSTRACT
The Community Engagement Core (CEC) supports the Strategic Vision of the CEET to improve
environmental public health in communities in Philadelphia and surrounding S.E. Pennsylvania.
It engages stakeholders to identify environmental health problems and address them
collaboratively. Bi-directional communication of ongoing Center environmental health research to
community stakeholders and of environmental health research needs from community
stakeholders back to CEET investigators is facilitated by the CEC’s strong partnerships with three
major audiences: (a) target communities; (b) health care professionals; and (c) policy and decision
makers. Through our “Target Community Model,” we first learn about the spectrum of community
concerns and then address environmental health problems without imposing any external
agenda. Our regional focus is on the aging infrastructure of post-industrialized cities e.g.
Philadelphia and its surrounding rural communities in Pennsylvania. In our target communities,
we focus on identifying vulnerable populations, including pregnant women and the elderly. The
CEC actively facilitates Community-Engaged Research (CER) and Community-Based
Participatory Research (CBPR) and implementation science strategies. We target resources to
those most in need which we refer to as precision public health. The CEC’s Stakeholder Advisory
Board, composed of CEET members and community stakeholders, prioritizes research questions
with a focus on CEET’s thematic areas in which we have considerable expertise: Air Pollution &
Lung Health, Environmental Exposures & Cancer, Windows-of-Susceptibility, and Environmental
Neuroscience, which unify concerns related to the impact of extreme weather events on health.
Research questions are often taken to the Translational Research Support Core for input on study
design to be performed by the Center which may determine the need to engage the Biomolecular
Mass Spectrometry Core and the Environmental Health Informatics Core. Our Target Community
Model allows for long-term and comprehensive engagement to enhance the communication of
environmental health information to improve public health. We seek out and engage policy and
decision makers by providing them with science to support improved public health policy including
municipal, state, and federal agencies. We actively translate and disseminate research
information through publication and presentation to ensure that communities, health care
professionals, and decision makers have the most current research information on which to act.
We have presented research information to local and national audiences. Our CEC leverages
multi-directional engagement regularly to expand the impact of our funded work and promote
active collaboration for improved health outcomes. By collaborating with the network of other
CECs, we have designed innovative community engagement tools and worked on projects with
national scope and impact.